Engaging African American Couples in the Management of Obstructive Sleep Apnea

ABSTRACT
Obstructive sleep apnea (OSA) affects 26% of adults over age 30 and is associated with significant
morbidity and mortality. At the time of presentation, African American have more severe OSA and have
more associated complications compared to other groups. Continuous positive airway pressure (CPAP)
is an effective treatment for OSA that improves sleepiness and quality of life in a dose response fashion.
Therefore, it is recommended that patients use it whenever they sleep. However, CPAP use among
African Americans is low. Many patients with OSA visit a health care provider at the urging of their bed
partners who themselves may be experiencing decreased sleep and quality of life due to their partners’
OSA. We reasoned that bed partners may positively effect CPAP adherence. We conducted interviews
of African American patients with OSA and their bed partners. They recommended a couple-oriented
intervention to increase CPAP adherence. With their help we developed a couple-oriented behavioral
therapy intervention.
We now propose a full scale randomized controlled trial involving 220 African American patients with
OSA of 2 large, urban healthcare systems and their bed partners. Patients randomized to the usual care
arm will receive a CPAP machine and supplies with standardized OSA and CPAP education from a
certified sleep technician. Patients and bed partners in the intervention arm will also receive a CPAP
machine and supplies with standardized education regarding OSA and CPAP from a certified sleep
technician. In addition, patients and partners will receive tailored text messages encouraging CPAP
adherence. The couples will receive five 1-hour virtual cognitive behavioral couple therapy sessions with
a behavioral sleep psychologist. Primary analyses will compare CPAP adherence at 1 year. Secondary
analyses will compare CPAP adherence at 1, 3, and 6 months. We will also measure the duration and
quality of sleep, functional status, and quality of life of patients and their bed partners.
Novel features of the proposed project include a rigorous randomized controlled trial design, short- and
long-term follow-up, and remotely monitoring of daily CPAP adherence data directly from the machines.
The project has the potential not only to improve patient sleep and well-being but also to improve the
sleep and well-being of their bed partners. Furthermore, it may serve as a model for future trials of
couple-oriented therapy among patients with other sleep disorders.

Public health relevance
PROJECT NARRATIVE Obstructive sleep apnea (OSA) is a common disorder with adverse health outcomes that can be life threatening when inadequately treated, particularly among African American patients. Continuous positive airway pressure (CPAP) is effective in treating moderate to severe OSA, yet few African American patients use it regularly. This proposal seeks to determine the efficacy of a couple-oriented multi-modality intervention for African American patients with OSA and their bed partners on CPAP adherence, duration and quality of sleep, functional status, and quality of life.